Functional consequences of bacterial-fungal dysbiosis in E/VLBW infants

Abstract
Bacteria deliver a significant functionality (e.g., metabolic capability) in the gut microbiome of humans;
however, Archaea and microeukaryotes (fungi and protozoans) exert important influences that are only starting
to be explored. These polymicrobial interactions help regulate the expansion and overgrowth of opportunistic
organisms, and serve important roles in shaping immune responses. Fungal communities, for example, can be
acquired vertically during birth or from the environment and serve important roles in shaping the composition of
bacterial communities in ways that are not yet fully understood. Extremely and very low birth weight (E/VLBW)
preterm infants are born with very immature immune systems and are particularly vulnerable to invasive
infections, so they are often treated with broad-spectrum antibiotics and antifungals. These premature infants
spend the most amount of time in the neonatal intensive care units and experience a variety of stressors. The
use of broad-spectrum antimicrobials likely has long-term impacts on the developing bacterial and fungal
communities that colonize the infant gut, and this in turn may impact long-term health. And because the
metabolic potential of the gut microbiome is a product of the interactions of prokaryotic and eukaryotic
microbes, there is an urgent need for ‘microbiome’ studies to incorporate more comprehensive approaches
(e.g., multi-omic) to capture the gene products and signature metabolites impacting functional interaction
networks. We have shown that prematurity among E/VLBW infants includes a significant dysbiosis that likely
impacts key metabolite signatures that may influence nutrient sensing and/or calorie processing capabilities, in
ways that can impact growth and development. This study will leverage banked temporal stool samples from
E/VLBW infants, many of which were followed until the age of 4, to evaluate functional metabolic networks via
metagenomic sequencing and metabolomics. Early changes to the microbiome may also contribute to or
predispose later health, such as metabolic dysfunction and obesity. We propose that the products of a
perturbed E/VLBW infant gut microbiome are linked to long-term health consequences that are not yet fully
understood, but likely include effects on nutrient sensing, metabolic processing of caloric intake, and
subsequent growth in the first few years of life.

Public health relevance
PROJECT NARRATIVE Extremely (<1kg) and Very Low (<1.5kg) Birth Weight (E/VLBW) premature infants spend the most amount of time in hospital neonatal intensive care units (NICU), experience the most stress, the most separation from their mothers, and receive the most amounts of broad-spectrum antimicrobials. This NICU experience has long-term impacts on the developing bacterial and fungal communities that colonize the gastrointestinal tract. This project will study functional changes to the developing infant microbiome that are dependent on proper transkingdom interactions among bacterial and fungal communities.